Specialized Training: Demography and Economics of Aging - Renewal 01 - Renewal

The University of Chicago (UC) proposes to continue the UC Specialized Training Program in the
Demography and Economics of Aging program, that began in 1994, and requests funded trainee
positions for 4 predoctoral fellows and 3 postdoctoral fellows per year. Housed in the interdisciplinary Center for Health and the Social Sciences (CHeSS), the NIA T32 Program draws upon the substantial and complementary resources, faculty, and expertise from across social science disciplines and related professional schools on UC’s campus, including the Social Science Division’s Departments of Economics, Sociology, and Comparative Human Development; the Biological Division’s Departments of Medicine and Public Health Sciences; the Harris School of Public Policy; the School of Social Service Administration; and the affiliated National Opinion Research Center (NORC). Our program’s record of trainee productivity and placement is excellent, as is the pool of trainees from which we select., As in past cycles, the program will continue to offer trainees a group of peers and mentors from a range of
academic disciplines; an interdisciplinary Demography Workshop (DW) which brings both internal and external speakers to present aging-related demography research; a program-specific Postmortem Seminar, following the DW, that allows trainees in the program to discuss the presentation with their peers and faculty leaders; formal coursework opportunities in aging; and training in the Responsible Conduct of Research (RCR). This newest iteration will also enhance existing training opportunities through the expansion of the potential mentor pool, provide formal training in Methods to Enhance Reproducibility in Research and facilitate social survey methods training, increase the number of postdoctoral fellowship positions from 2 to 3 per year, and leverage the newly funded NIA P30 Center for Healthy Aging Behaviors and Longitudinal InvestigationS (CHABLIS) to increase training in longitudinal studies that examine how demographic and economic factors facilitate or suppress individual healthy aging behaviors across the life course. In addition, Kathleen Cagney, PhD, Professor of Sociology, who has served on the NIA T32 Committee on Demographic Training (CDT) Executive
Committee (EC) for 12 years, will assume responsibilities as Program Director (PD) and Colm
O’Muircheartaigh, PhD, Professor of Public Policy, will join the program leadership as Co-Director. Linda Waite, PhD, the George Hebert Mead Distinguished Service Professor of Sociology, who has served as PD of the program since its inception, will continue to be closely involved in the oversight of the program as a member of the CDT EC along with Dan Black, PhD, and David Meltzer, MD, PhD.

Public health relevance
This program trains exceptional predoctoral and postdoctoral students as researchers in the demography and economics of aging. These trainees will use innovative methods in social science research and produce, over their careers, research findings directly relevant to public policy and public health, and will focus on such topics as demographic change, health across the life course, mental health, access to health services, and other health outcomes throughout the population.